Integrated multi-tissue 13C flux analysis platform to assess renal metabolism in vivo

PROJECT SUMMARY/ABSTRACT
Prior studies have assessed disease-associated changes in metabolic fluxes within a single organ but have not
attempted to simultaneously examine flux alterations within multiple organs that together control whole-body
nutrient metabolism. Furthermore, current isotope tracer technologies do not have the ability to dissect
metabolic flux differences between spatial locations within a single organ. The overall objective of this proposal
is to develop a multi-tissue 13C metabolic flux analysis (MFA) platform to assess kidney metabolism and its
interrelationship with liver and heart metabolism. The rationale for this technology is that it will enable
investigators to address important questions about in vivo regulation of renal metabolism that cannot be
answered through studies of single organs or isolated cells/tissues. The research builds from our recently
published study wherein renal and hepatic contributions to gluconeogenesis (GNG) were simultaneously
assessed in fasted mice. To our knowledge, this was the first time 13C MFA had been applied to assess
interactions between liver and kidney fluxes in a live animal. There is now a critical need to, first, expand
this flux measurement technology to include glycolytic tissues and, second, test whether regional differences in
metabolic fluxes can be distinguished within the kidney. The first aim will establish a multi-organ 13C MFA
platform to simultaneously quantify in vivo metabolism of gluconeogenic and glycolytic tissues of the kidneys,
liver, and heart. Mice with veinous and arterial catheters will receive 13C-glucose infusions during
hyperinsulinemic-euglycemic or hyperinsulinemic-hypoglycemic clamps. In each condition, the isotopes,
measurements, and mathematical modeling procedures will be optimized to precisely determine metabolic
fluxes in each tissue. We will then apply this novel platform to assess metabolic flux alterations in a relevant
animal model of diabetic kidney disease: BKS db/db mice with endothelial nitric oxide knockout (eNOS−/−). The
second aim will expand 13C-labeled metabolite measurements to assess spatially resolved metabolism in the
kidney. Untargeted high-resolution LC-MS/MS profiling will be applied to tissue extracts, and metabolites
enriched by 13C-glucose will be identified using novel software that screens for hits against the KEGG
Compound Database. Then, MALDI-based imaging mass spectrometry (IMS) of kidney tissue slices will be
applied to locate these labeled metabolite features, determine their spatial patterns of 13C enrichment, and
perform 13C MFA to assess metabolic fluxes within different kidney regions. The proposed research is
innovative because it will establish new technologies for quantifying flux phenotypes of integrated multi-tissue
metabolic networks in live animals. The analysis platform will be implemented as a core service of the
Vanderbilt Mouse Metabolic Phenotyping Center and Vanderbilt O’Brien Kidney Center. The research is
significant because it will enable future studies to assess how metabolism is dysregulated during progression
of kidney disease and how treatments that target renal pathways impact whole-body metabolic health.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will establish novel approaches for studying in vivo metabolic flux regulation in the kidney and interactions with the liver and heart. This flux analysis platform will be applied to understand metabolic changes that underlie the pathogenesis of diabetic nephropathy and chronic kidney disease. The research is particularly relevant to the part of the NIH mission that seeks fundamental knowledge to enhance health and reduce illness.